The CU Learning Disabilities (LD) Leadership Core: Scaffolding a Growing Center of Environmental LD Research and The Next generation of LD Scholars

The Leadership Core of the Columbia Psychiatry, Psychology, and Public Health Collaborative LD
Innovation Hub will train the next generation of LD researchers to take on transdisciplinary, impactful work by
learning to conduct cutting-edge neuroscience and engage with the wider child educational system. To do this
we will build an integrated leadership training infrastructure, providing state-of-the-art neuroscience research
training, and delivering a translational science training program—all aimed to prepare early investigators with
skills needed to bridge the gap between learning difficulties (LDiff) research and best practices in the
educational system. Our framework uses a bidirectional hub and spoke model, linking the embedded research
project (the hub) with a network of community sites in which trainees work with practitioners/learning
specialists in the educational system and provide feedback to the research study with respect to community
needs and communication challenges. The hub will train early career scientists to conduct cutting-edge
neuroscience to explore the biological and cognitive pathways linking environmental chemical and social
exposures to LDiff. The spokes of the model comprise the translational component, in which early investigators
receive training in how to engage with and listen to community members, and translate community needs and
relevant research to practitioners, educators, and policy-makers who are responsible for making change in
educational settings. The Leadership Core will thus prepare the next generation of LD research scientists with
a full set of research, communication, and leadership skills, spanning neuroscience, epidemiology, systems
thinking, and dissemination & implementation science. The core will develop an administrative and training
infrastructure for the overall LD Innovation Hub, deliver a state-of-the-art biological/neuroscience research
methods training program, and implement a translational science training program with didactic and
experiential components.
IMPACT: Our Leadership Core expands the LD research paradigm by training future leaders in
neuroscience and analytic techniques (the hub), linked to a translational community-based practicum
experience in disadvantaged educational communities (the spokes). We go beyond community
participatory research to prepare future LD leaders with practice-based communication, listening, and
engagement skills, enabling them to become independent investigators, faculty members, and
spokespersons for children from economically disadvantaged families who suffer disproportionately
with learning difficulties, thereby helping to close the gap between research and practice.